Pilot Research

The goal of the pilot research program is to promote innovative research in cancer and aging related to the three theme areas we have chosen; immunobiology of aging and cancer, treatment tolerance and efficacy in the context of aging comorbidity and behavioral/social issues. Pilots will be selected based on responsiveness to the goals of the program; evidence of involvement of and plans for collaboration between scholars in cancer and aging, specific plans and potential to lead to independent external funding, feasibility in the financial and time frame proposed and traditional measures of quality including significance, approach, innovation, investigator and environment.